TRIO NRSA Training Core

Today’s incipient and early career trainees in Kidney, Urologic, Hematologic (KUH) fields require training
within environments richly populated by accomplished team-science researchers and adept, committed mentors.
Trainees must learn sophisticated research tools while simultaneously completing didactic coursework and
developing professional development skills. Coordinating these efforts will enable scale-up of high-impact
practices to remove the daunting academic and social barriers that have caused persistent disparities among
KUH clinicians and researchers, and the direct gains of this training program will be realized most by the KUH
patient populations we serve. Training the next generation of KUH researchers requires institutions and mentors
to synergistically engage in both research and training. We have brought together KUH researchers at 3 leading
North Carolina (NC) biomedical research universities: University of North Carolina-Chapel Hill, Wake Forest
University, and Duke University, as well as from 3 Historically Black Colleges and Universities, NC Agricultural
& Technical State University, Winston-Salem State University and NC Central University. Together, this forms
the NC KUH TRIO (Training, Research, Innovation, Outreach, or TRIO) U2C/TL1 Research Training Program.
The TRIO Training Core has 3 objectives: 1) provide didactics and hands-on experience in rigorous
basic/translational and clinical sciences research; 2) conduct research that includes adoption of emerging
technologies and builds on the cross-disciplinary and cross-institutional team science across the KUH mission;
and 3) establishes and nourishes a community of scholars that expands and sustains diversity in KUH research.
Multidisciplinary and team research skills will be developed under the Professional Development Core in
conjunction with Clinical and Translational Science Award (CTSA) programs. A connected community of TRIO
scholars, that spans from high school to early faculty, will be built and supported by the Networking Core.
Qualified and motivated TRIO mentors will train both pre- and post-doctoral trainees across broad, highly
relevant KUH scientific specialties that span basic/translational, clinical, and technology arenas. Emerging
mentors will mature to assure future leadership and longevity of the program. TRIO will exploit existing multi-institutional training infrastructures and programs in biotechnology, public health, translational science, and
clinical research. A robust and transparent admissions process with targeted recruitment will foster diversity, and
rigorous program evaluation will allow real-time improvement in serving the needs of our KUH trainees. The
integrated TRIO program will leverage cross-institutional synergies and provide cohesive programming to train
the next generation leaders in multidisciplinary and team KUH-relevant research.